MULTICENTER ISRADIPINE SALT TRIAL (MIST)

This research project is designed to determine if isradipine lowers blood pressure as effectively on high vs. low salt diets. The hemodynamic response to isradipine on both diets is also measured.